FAT cadherins and vascular remodeling

FAT cadherins and vascular remodeling
Vascular remodeling is a critical process in the pathogenesis of major vascular diseases such
as atherosclerosis, restenosis, saphenous vein graft occlusion, and transplant-associated
arteriosclerosis. Factors that control the activities of vascular smooth muscle cells (SMCs)
during vascular remodeling remain incompletely understood. Fat cadherins belong to an ancient
family of large, single pass type I transmembrane proteins found throughout Metazoans;
conserved functions of these proteins affect cell growth and polarity and span from Drosophila
to mammals. The FAT1 cadherin is expressed by SMCs in multiple animal models of vascular
disease and in injured human arteries. We have found that inactivation of the Fat1 locus in
SMCs permits dramatic increases in proliferation and neointimal formation in a mouse model of
vascular injury. Interestingly, the FAT1 molecule undergoes complex processing: while cleavage
and translocation of the FAT1 intracellular domain (ICD) to the cell nucleus was reported
several years ago, we found an accumulation of FAT1 fragments within mitochondria, wherein
these FAT1mito species interact selectively with inner membrane proteins and exert critical
regulatory control over oxidative phosphorylation, limiting the activities of respiratory Complexes
I and II and inhibiting cell growth. FAT1 also has substantial effects on SMC gene expression,
promoting expression of SMC marker genes both in vitro and in vivo; interestingly, the FAT1ICD
is also found in the cell nucleus, raising the possibility of more direct involvement in gene
regulation. In this project, we will assess how FAT1 signals from different locations within the
cell, and assess whether these activities are complementary, oppositional, or overlapping to
control SMC phenotype. We will investigate intra- and extracellular sequences in FAT1 and
interactions with structurally-related proteins FAT4 and DCHS1 that may control how FAT1 is
processed and thereby directed to distinct compartments. To assess relevance to key disease
processes in vivo, we will assess how these signaling activities affect vascular remodeling and
atherosclerosis in mouse models.

Public health relevance
Narrative These studies are relevant to obstructive vascular disease, an important process that is the root cause of myocardial infarctions (‘heart attacks’) and strokes. Obstructive vascular disease results from changes in cells in blood vessel walls as they respond to various stresses and disease conditions, including high blood pressure, high cholesterol, diabetes, smoking, and genetic factors. We focus here on a protein called FAT1 that controls the production within cells of energy and biochemical ‘building blocks’ necessary for cell growth and other activities, and also affects gene expression. We believe that these different effects of FAT1 arise from fragments of the protein that are located in distinct compartments within cells. The studies we propose here are designed to understand how these FAT1 fragments control important cellular activities, and how these activities in turn affect the development of vascular obstruction. Such understanding may lead to new ways to intervene to decrease vascular obstruction.